Retrieval-Induced Facilitation in Real-World Scenarios

Project Summary
Episodic memory, or the retrieval of information from events, is a complex process that is dynamic in nature.
When retrieving this information, there are changes that occur. These changes can either enhance (i.e.
retrieval-induced facilitation [RIFA]) or inhibit (i.e. retrieval-induced forgetting) memories for other, related
information, and the mechanism of this enhancement/inhibition is unclear. In previous research, these
concepts have been explored in studies using static images, word pairs, or literary passages to test these
phenomena. In real life, we receive a constant, continuous stream of information that we segment into events
with distinct boundaries. There is good reason to believe that retrieving one part of an event might lead to RIFA
for other parts of the same event, but that event boundaries might restrict the benefits of retrieval practice. I
propose to use an innovative behavioral paradigm in combination with computational modeling to address how
retrieval impacts memory for naturalistic events. I have developed a task in which participants are exposed to
videos depicting relatable events (i.e. going grocery shopping) that are separated by event boundaries. Aim 1
is to understand the relationship between RIFA and event segmentation. Based on prior research indicating a
connection between memory retrieval and event segmentation, it is proposed that retrieval practice will
facilitate retention of other information from the same event, but RIFA will not occur between events. In Aim 2,
using computational modeling, we propose a possible mechanism of RIFA. Based on prior models, such as the
Complementary Learning Systems (CLS) model, this mechanism likely involves both error-driven and Hebbian
learning, with emphasis on the connection between the entorhinal cortex, the hippocampus, and the neocortex.
In the proposed study, we will expand upon previous models on RIFA to better characterize the relationship
between these regions in event-based, realistic scenarios. We expect that with retrieval practice the
hippocampus will become more efficient at driving learning in the neocortex, which will ultimately lead to better
accuracy for information within the same event as the retrieval practiced information due to a shared event
context. Starting with a simple context change to mimic a change in event, we will increasingly make the model
more complex by training the model to use prediction errors to mark event boundaries, then ultimately,
inputting naturalistic videos to best mimic a real-life scenario. This project builds on my previous work and
addressing these aims will give me new training in the most advanced methods in cognitive neuroscience,
specifically computational modeling. More broadly, we have shown that memory retrieval practice can be a
clinically valuable approach in patients with schizophrenia (Ragland et al, 2020), and these studies will give us
the information we need to optimize this method to enhance everyday episodic memory in psychiatric
populations.

Public health relevance
Project Narrative Retrieval of information within events is important in everyday life and influences how one interacts with their environment. Research into ways to enhance memory for this information and how this mechanism works can be used to support strategies to optimize memory performance in populations with memory deficits that contribute to life-long impairments in everyday life, such as people with schizophrenia.